Prenylation in antiviral immunity

Summary
In this proposal, we will explore the role of prenylation in antiviral immunity. Prenylation is a post-translational
modification that renders proteins hydrophobic, thus targeting them to the endomembrane. While the role of
prenylation in immunity is unclear, our preliminary data shows compelling evidence that prenylation is a
modification widely used in innate antiviral immunity. As both the host and virus utilize prenylation and the
cholesterol biosynthetic pathway, we propose a dynamic host-pathogen interaction at this interface. We
hypothesize that prenylation could be a potent host innovation to counter viral pathogenesis. This is based on
in silica analysis that revealed an enrichment of immunity-related proteins with a prenylation motif. We
followed in-silica analyses with a biochemical screen and identified several prenylated antiviral proteins that
are involved in interferon responses and virus restriction, with potential to affect virus entry, replication, and
egress. In this grant, we propose to identify the functional consequences of prenylated proteins on subcellular
localization, interferon signaling, and antiviral function. By perturbing specific enzymes in the prenylation
pathway, we will study its effect on interferon response, antiviral effectors, and virus control. This work will
provide novel insights into cell-intrinsic antiviral countermeasures and the development of novel antiviral drug
targets.

Public health relevance
Project Narrative The proposed study will provide novel insights into the location-specific functions interferon induced genes play in coordinating innate antiviral responses during viral infections.